PDX tumor-TME acquired resistance

Project hypothesis and Specific Aims: We hypothesize that the molecular subtypes of EGFR and KRAS
mutant NSCLC tumors with acquired mutation targeted drug resistance are associated with an
immunosuppressive TME including both immune and non-immune stromal cells that can be therapeutically
targeted in a way that will enhance the efficacy of drugs targeted to intrinsic resistance pathways.
Specific Aim 1: Develop and characterize existing and new models of mutant EGFR and KRAS inhibitor
acquired resistance including PDXs and PDX-derived organoids and characterize mechanistic
relationships between molecular subtypes and the TME, including immune and non-immune stroma.
Characterization will include histology, immunohistochemisry (IHC), RNAseq, and MS proteomics. We will
identify specific molecular alterations that can be functionally tested and determine their effect on the TME.
Examples being tested currently include 3-phosphoinositide-dependent kinase 1 (PDK1, PDPK1) expression,
SETD1B inactivating mutations, and YAP (yes-associated protein) expression. We will test drugs that target
specific cells in the TME to enhance the immune response. We are currently targeting M2 tumor associated
macrophages (TAM). Osimertinib and G12C KRASi resistant PDXs and organoids will be interrogated to identify
acquired drug resistance molecular pathways using MS proteomics, scRNAseq, and CRISPR screens.
Specific Aim 2: Define treatment strategies in mutant EGFR and KRAS inhibitor acquired resistance
models based on targeting pathways (e.g., PDK1, YAP, NF-B) implicated in current and future studies
of acquired resistance caused by tumor-TME cell networks (e.g., CSFR1, CD74). Potential drug targets for
overcoming acquired resistance to osimertinib (see preliminary data) include PDK1, YAP, NFkB, and TAM. We
will develop therapeutic approaches based on TME characterization. H1975R has a more immune stimulatory
TME than PC9 YAP thus providing a rationale for testing checkpoint blockade combined with PDK1 inhibition in
H1975R. M2 polarized macrophages are increased in PC9 overexpressing wtYAP thus providing a rationale for
testing TAM inhibition in PC9 YAP with a CSFR1 inhibitor. Residual tumors after osimertinib and KRAS G12Ci
will be characterized following treatment using MS proteomics, scRNAseq, and CRISPR screens to identify novel
acquired resistance pathways. The functional role of specific targets in acquired drug resistance will be validated
using CRISPR KO. We will develop new models to include future novel drugs developed to target these and other
pathways.